Organoid modeling of pre-metastatic niche formation in the liver by primary colorectal tumor secreted factors

Metastatic disease remains the primary cause of cancer-related deaths. In colorectal cancer (CRC), the liver is
the primary site of metastases; and, the majority of patients diagnosed with CRC die as a result of their hepatic
metastases. This provides a powerful motivation to study the mechanisms behind the complicated metastatic
cascade, hopefully leading to novel approaches for intervention. However, studying the biological mechanisms
that contribute to metastatic disease has been difficult. One such target for research that has arisen recently is
the pre-metastatic niche (PMN), which forms distant from the primary tumor, but creates favorable environments
for metastasizing cells to take hold. Studying the PMN is challenging, as in animal models it is nearly impossible
to predict when changes might happen in the PMN, and after identification of metastases, it is too late. A
clinically-relevant in vitro model in which metastasis and the changes to tissues leading up to metastasis can be
observed and manipulated would be an invaluable resource for probing these mechanisms and for identifying
ways to circumvent them. Our team has now published several papers describing our bioengineered in vitro
metastasis-on-a-chip (MOC) platform that is comprised of microfluidic devices and 3D extracellular matrix (ECM)
hydrogel-based tumor and tissue organoids. Our objective is to use these tools to identity and pinpoint early
changes to the liver PMN that occur because of primary tumor-secreted mediators and assess their contributions
to CRC metastasis. We will accomplish this by employing 3D liver, CRC, and bone marrow hematopoietic
progenitor cell (BM-HPC) organoids, contained in a microfluidic platform to quantify liver remodeling and BM-
HPC recruitment, and in turn, how this remodeling influences the likelihood and kinetics of in vitro metastasis.
We hypothesize that within our novel bioengineered in vitro platform, secreted mediators from tumor cell line
organoids and patient-derived tumor organoids (PTOs) of varying grade will induce a corresponding spectrum
of ECM remodeling, architectural dysregulation, and BM-HPC recruitment, which when heightened, corresponds
with increased metastasis. In Aim 1, we will subject primary human liver and BM-HPC organoids to CRC
conditioned media, measure hepatic stromal (stellate) and immune (Kupffer) cell activation, and quantify ECM
remodeling in terms of composition, architecture, and mechanical properties. As part of this aim, we will dissect
out the relative contributions of stellate cells, Kupffer cells, and BM-HPCs to these changes. In Aim 2, our MOC
device will include tumor organoids in addition both the liver and BM-HPC organoids and we will assess PMN
formation in this dynamic multi-tissue platform. Metastasis from the tumor to liver organoid will be measured.
This will enable us to link changes of the PMN to metastatic events. Ultimately, these studies will provide
opportunities to identify tumor cell secreted mediators and distinct features of the PMN that could potentially
serve as future targets of the early metastatic process prior to becoming incurable as well as biomarkers for
prediction of metastasis in patients.

Public health relevance
PROJECT NARRATIVE Colorectal cancer often leads to metastasis in the liver and the ultimate cause of death in the majority of these patients is metastatic disease. Recently, the concept of the pre-metastatic niche (PMN) has gained clinical importance in which soluble mediators secreted from primary tumors result in cellular and tissue changes in distant organs to promote future engraftment and growth of circulation tumor cells. In this proposal, we aim to use novel bioengineered 3D organoid technologies, paired with a unique metastasis-on-a-chip platform, to quantitatively investigate how colorectal tumors induce PMN formation in the liver, which subsequently impacts the likelihood of metastasis.